Slowing Atherothrombosis Progression through Indoor Air Filtration: A Crossover Trial in Hispanic and non-Hispanic Adults with Ischemic Heart Disease History

ABSTRACT
Cardiovascular disease (CVD) is the leading cause of death in the US. There has been an increasing
recognition of the important contribution of fine particulate pollution (PM2.5) to CVD morbidity and mortality.
Mounting evidence suggests that the use of indoor air filtration to reduce PM2.5 exposure from days to weeks
leads to improvement in acute atherothrombosis biomarkers. However, no trials have assessed whether these
short-term effects are sustained or further improved with prolonged filtration. The proposed study is the longest
intervention trial investigating the effect of using low-cost air purifiers in residences on ameliorating
atherothrombosis progressions in vulnerable individuals. The study will examine atherothrombosis responses to
HEPA filtration across and within four subgroups of male or female and Hispanic or non-Hispanic participants.
We will leverage the diverse population in Los Angeles to investigate the effect of indoor PM2.5 filtration on both
levels and slopes of change in atherothrombosis biomarkers including arterial stiffness, blood pressure, targeted
proinflammatory and prothrombotic markers, and novel proteomic makers, as well as CVD risk score. The focus
on the slopes of change over time is novel and will provide better prediction of future CVD events and mortality
than biomarker level changes assessed in previous studies. We have an experienced team of investigators at
the University of Southern California (USC) and Duke University and will leverage the rich patient resource from
the USC KECK electronic medical records and the linked census-track PM2.5 data to enroll 100 participants of
65-84 years old non-smokers with a history of ischemic heart disease (clinically stable for at least 6 months) who
have lived in the census track with higher ambient PM2.5 exposure in the past years. Participants will be block-
randomized to two intervention arms (HEPA or sham filtrations, each of 9-month duration) and crossed over to
the other intervention arm after a 3-month washout period. This design allows us to conduct the two intervention
arms in the same calendar months of two consecutive years. Three home visits will be conducted during each
intervention arm to set-up and calibrate air monitors, measure health outcomes, and collect biospecimens.
Lifestyle and health covariates will be collected through online questionnaires. The crossover design and timing-
controlled interventions will reduce the influence of confounding factors since participants serve as their own
controls in the within-person comparison. Indoor and outdoor PM2.5 and co-pollutants will be measured; and
meteorological data as well as wildfire events will be recorded throughout the trial. These covariates will be
adjusted for in the statistical analyses. Our aims match the goal of NOT-HL-20-788 calling feasibility trials to
investigate the effects of portable air cleaners on reducing PM2.5 exposure and CVD biomarkers including novel
omics markers. Findings of the proposed study will provide the efficacy and feasibility data to support future
nationwide or multi-center trials to further investigate the air filtration effect on adverse CVD event incidence and
mortality.

Public health relevance
PROJECT NARRATIVE The proposed study is aimed to test the efficacy and feasibility of using air filtration to ameliorate atherothrombosis progression. This project may have international impact on identifying effective and affordable methods to reduce personal air pollution exposure and prevent cardiovascular disease morbidity and mortality.